Training Program for Applied Research and Development in Genomic Medicine

Abstract
Healthcare professionals, scientists, and the public are embracing the potential advances in healthcare
that are possible, and in some cases being delivered now, through approaches that employ genomic
and other personal information to improve care. To ensure these expectations become reality requires
a highly qualified cadre of clinician-scientists, scientists and clinicians working collaboratively to
advance discoveries and implementation in genomic medicine. We propose a new post-doctoral
genomic medicine training program called “Program for Applied Research and Development in
Genomic Medicine or PARADIGM”. This training program for MDs, PharmDs, other clinical specialists
at the doctoral level, and PhDs is based on four premises: Genomic medicine: 1. will be led primarily by
doctorally-trained clinicians and a team approach is essential. 2. needs clinical translational scientists in
with core competencies in translational science, and specialized knowledge in genomic medicine. 3.
will require leaders, and this program will foster development of leadership and professionalism. 4. will
improve lives through scientific leaders in academia, healthcare, the private sector, governmental
regulatory science and policy, among other sectors. To train individuals to meet these needs,
PARADIGM will provide up to 4 post-doctoral scholars a multi-year, integrated, multidisciplinary
program to prepare them for a career in genomic medicine. Broadly, the program is comprised of four
major components: 1) a Didactic component of required and optional coursework; 2) a Mentored
Research component involving a defined research project under the mentorship of an accomplished
genomic medicine scientist and clinician; 3) a Clinical Genomic Medicine component that integrates
them into the genomic medicine clinical practice setting; and 4) a Professional Development
component including experiential training through presenting at national meetings, participating in grant
and budget reviews, mentoring students and other activities. The mosaic of training experiences
across these four components will be tailored according to the previous experiences, educational needs
and research interests of the trainee, but will be concentrated in three cores of expertise at UF:
pharmacogenomics, cancer genomics, and disease susceptibility genetics/genomics. We will rely on
36 highly talented, collaborative, multidisciplinary mentors to execute the program. PARADIGM will
undergo continuous evaluation and quality improvement to ensure long-term success of the trainees.
Upon program completion, each trainee will be expected to possess knowledge and skills that will
enable them to manage the challenges of evidence generation and clinical use of genomic medicine.

Public health relevance
Program Narrative The overall goal of this post-doctoral training program in genomic medicine is to provide clinical/translational scientists with a multiyear training program comprised of didactic, research, clinical genomic medicine and leadership training. At the end of this two-three year period, trainees will possess the knowledge and skills required to integrate genomic medicine into their clinical, scientific, public health/regulatory or industrial careers.